Mechanisms of immune evasion by a neuroinvasive fungal pathogen

Project Summary
Cryptococcus neoformans is a neuroinvasive yeast that causes fatal meningitis in immunocompromised
individuals, resulting in >180,000 annual deaths representing 15% of global AIDS-related mortality. Cryptococci
initiate infection in the lungs, where they must overcome host innate immunity to establish a replicative niche
and disseminate to the central nervous system. Dectin-1 is a critical pattern recognition receptor (PRR) that
initiates antifungal defenses in response to β-glucans, a pathogen-associated molecular pattern (PAMP)
ubiquitous in fungal cell walls. While Dectin-1 is essential for defense against important pathogens such as
Candida albicans and Aspergillus fumigatus, this receptor fails induce protective responses during C.
neoformans infection, despite the presence of β-glucans in the cryptococcal cell wall. This suggests that
cryptococci employ yet-undiscovered mechanisms to evade Dectin-1 sensing. The objective of this proposal is
to define these mechanisms. To accomplish this, I will test the central hypothesis that C. neoformans evades
Dectin-1 sensing using virulence factors that shield PAMPs and/or suppress host inflammatory signaling.
Specifically, I aim to 1) identify fungal genes necessary for Dectin-1 evasion and 2) determine the relative
contributions of PAMP shielding and inflammatory suppression to this process. Preliminary work in the Madhani
lab has produced a library of >4000 well-validated, single-gene C. neoformans deletion strains, and I have
developed a robust sequencing-based workflow to quantify these mutants in complex pools. Leveraging these
tools, I will systematically identify fungal virulence factors required for Dectin-1 evasion using an in vivo murine
pulmonary infection model and an in vitro macrophage stimulation model. To then define mechanisms of Dectin-
1 evasion, I will profile Dectin-1 evasion mutants for diverse phenotypes diagnostic of roles in either PAMP
shielding or inflammatory suppression. This will classify novel evasion factors as acting through one or both of
these mechanisms, thereby revealing the extent to which PAMP shielding and inflammatory suppression
influence Dectin-1 evasion. Thus, by identifying the factors that subvert a key antifungal sensing pathway and
defining the mechanisms through which this pathway is neutralized, this work addresses an important knowledge
gap in cryptococcal pathogenesis and will provide a foundational understanding for how invasive fungi overcome
innate defenses.

Public health relevance
Project Narrative Cryptococcus neoformans is an invasive fungal pathogen that causes >180,000 annual deaths representing 15% of AIDS-related mortality. Evasion of host innate immunity is central to C. neoformans pathogenesis, yet the underlying mechanisms remain unclear. This proposal aims to dissect the fungal virulence factors involved in evasion of the antifungal sensor Dectin-1, thereby revealing the molecular basis for subversion of a critical defense pathway.